A novel CAR-T cell therapy for the one-time treatment of chronic HIV infection in patients who are not ART suppressed

Abstract
Building on our successful primate model studies, we aim to develop a one-time treatment for durable remission
of human immunodeficiency virus (HIV) in the absence of antiretroviral therapy (ART). This targeted treatment
is an autologous HIV-specific chimeric antigen receptor (CAR)-T cell therapy that employs a CXCR5 “homing
device” to direct anti-viral killer T cells into B cell follicles where they can eliminate virus-producing cells. B cell
follicles are a “hidden” immune protected site that permit viral replication due to low levels of virus-specific CD8
T cells. Our preclinical CAR/CXCR5-T cell pilot studies in a simian immunodeficiency virus (SIV)-infected rhesus
macaque model of HIV indicate that this immunotherapy is safe and effective in ART-treated animals. Our
funded STTR Fast Track grant proposed to investigate a similar therapeutic approach in chronically infected
non-ART suppressed individuals. In phase I studies, we will modify our original CAR/CXCR5 DNA construct to
confer optimized (opt)CAR/CXCR5-T cells with greater persistence, higher anti-viral binding affinity, and
resistance to SIV/HIV infection. In Phase II, we will develop a GMP-scalable method to produce human
optCAR/CXCR5-T cells for the first-in-human Phase 1 clinical trial, and this method will be used to produce
rhesus macaques optCAR/CXCR5-T cells for use in an IND-enabling preclinical study. The IND-enabling study
will assess the safety and efficacy of optCAR/CXCR5-T cells in an SIV model of chronic HIV infection. Here,
we are proposing to participate in the I-Corp program with a team consisting of: 1) C-level Corporate Officer,
Dr. Athanasiou; 2) Scientific Technical Expert, Dr. Sen; and (3) Industry Expert, Janet White. The team will be
led by Maria Athanasiou, PhD, co-founder and CEO of MarPam and Principal Investigator on the Parent Award.
Dr. Athanasiou has expertise in drug development, having led a team that developed an FDA approved drug
for the treatment of depression, managed a $100 M budget, and provided key contributions to market research
and marketing activities. Nandini Sen, PhD, Senior Scientist at MarPam, will participate as a technical expert.
Having joined MarPam after working as a Senior Scientist at Stanford University, Dr. Sen brings her vast
experience gained over a decade working in the laboratory of Dr. Ann Arvin, a renowned infectious disease
expert at Stanford. Rounding out the team, Janet White is a seasoned executive and industry expert with over
35 years of experience in international life science companies. In addition to her proven track record for
developing and implementing growth strategies and product development, she is a business adviser to
entrepreneurs and early-stage companies through accelerator and mentoring programs. All team members are
willing to commit at least 20 hours per week for the duration of the program and have a sincere desire to
investigate the commercial landscape surrounding the innovation. This team and the company will benefit
immensely from the I-Corps program and the MarPam C-level Corporate Officers are committed to incorporate
the learnings from this market research to revise its commercialization strategy.

Public health relevance
Project narrative We are developing a one-time treatment of autologous CAR-T cells for patients with chronic HIV infection who are not ART suppressed. Here, we propose to participate in the I-Corp program to accelerate the translation of our biomedical research to the marketplace.